High resolution profiling and computational modeling of influenza virus-immune dynamics during natural infection

Abstract
Seasonal influenza viruses (IVs) cause hundreds of thousands of deaths every year, despite widespread pre-
exposure and vaccination. To design more effective vaccines against both seasonal and pandemic IVs, there is
an urgent need to better understand how the complex interplay between viral and immune dynamics in humans
influence infection outcomes and transmission risk. Several critical fundamental knowledge gaps hobble the
development and evaluation of next-generation IV vaccines. One is that we have a very poor understanding of
which specific features of the enormously complex human immune response to IV can serve as reliable
correlates of protection from severe infection outcomes and forward transmission risk. This makes it difficult to
predict the performance of vaccine candidates in the human population. Similarly, we do not understand how
infection or vaccination drive the evolution of immune memory repertoires across highly heterogeneous
individuals. This makes it hard to design/evaluate novel antigens that reliably reshape the immune memory
repertoire to effectively protect against future strains. To address these critical gaps in our understanding of
functional IV immunity in humans, we will build upon a unique clinical study already underway on the University
of Illinois campus that uses a frequent PCR screening program to identify individuals during the first few days of
IV infection. By combining repeated blood draws with daily virus sampling following infection, we can generate
both an unprecedented high-resolution longitudinal profile of viral shedding dynamics and a rich, highly
multidimensional profile of immune status before, during, and after infection. Our multidisciplinary team of
experimentalists and computational modelers will fit the virological and immunological data we collect to
mechanistic models of virus-immune dynamics to infer key viral and immune dynamics features from each
infected individual. We will then apply novel statistical and machine learning approaches to achieve two primary
aims: (1) identify reliable immune correlates of reduced viral shedding and transmission risk, and (2) define how
both viral and host factors shape the evolution of the anti-IV B cell repertoire and functional antibody landscape.
Together, these aims will identify new host and viral features that correlate with desirable, protective memory
responses against IV that can be incorporated into the design and evaluation of next generation, universal IV
vaccines.

Public health relevance
Project Narrative: Influenza virus remains a critical global public health threat, responsible for an estimated 250,000-500,000 deaths each year. This proposal aims to generate high-dimensional, longitudinal viral and immune dynamics datasets from people infected with influenza virus and then use mechanistic mathematical models and cutting- edge statistics approaches to identify novel correlates of protection and immune repertoire evolution.